Mechanobehavior of Pseudomonas aeruginosa in shear flow

Abstract
Although shear flow in the human body restricts colonization by bacterial pathogens, our understanding
of how bacterial pathogens sense and respond to shear flow is limited. Recently, I combined
microfluidics and transcriptomics to discover that the human pathogen, Pseudomonas aeruginosa,
senses shear flow through a novel process, which I named rheosensing. Rheosensing uses the sigma-
factor FroR and anti-sigma factor FroI to tune gene expression to the speed of shear flow. Here, I
propose a systems-level approach to characterize the regulatory mechanisms of rheosensing. First, I
will use microfluidic-based transcriptomics to measure genome-wide changes in gene expression while
independently modifying the three parameters of shear flow: flow rate, channel dimensions, and
viscosity. Second, I will determine the regulatory targets of the rheosensing regulators FroR and FroI.
Third, I will couple fluorescence-activated cell sorting (FACS) with transposon sequencing (Tn-seq) to
identify additional sensory and regulatory proteins that control rheosensing. Together, these aims will
provide genome-wide characterization of the targets, signaling pathways, and flow sensors that control
rheosensing. As rheosensing is likely important for host colonization, this study will provide new insight
into the virulence of P. aeruginosa in host-relevant shear flow. Together, the research and career
development plans I outline here will help me obtain a faculty position at a research university, launch
my independent research program, and allow for a seamless transition to the next stage of my career.

Public health relevance
Narrative Pseudomonas aeruginosa is a human pathogen that infects many sites of the body rich in shear flow and I have recently discovered that Pseudomonas is capable of sensing shear flow through a process called rheosensing. Here I propose a systems-level approach to understand the targets of rheosensing, characterize the rheosensing regulators FroR and FroI, and identify new sensory proteins that control rheosensing. By providing a genome-wide understanding of bacterial rheosensing, I hope to provide a novel framework for the development of anti-virulence therapeutic strategies.